Stressors, adaptive factors, and developmental timing: Influences on Latino/a mental health from early childhood through young adulthood

Abstract
In 2021, the US Surgeon General issued an advisory warning of a youth mental health crisis. Latino/a youth have exceedingly high rates of internalizing symptoms such as depression and anxiety. Ecosocial theory posits that historical, societal, and ecological conditions over the life course have critical impacts on later mental health. This research will examine how distal and proximal stressors influence mental health trajectories for US Latino/a youth followed from early childhood into young adulthood. Distal stressors, such as economic stress, may increase Latino/a youth’s internalizing symptoms directly and indirectly through proximal societal stressors, such as families’ economic, health, and social problems. These kinds of stressors also may have direct and indirect effects on increased internalizing symptoms through family stress processes, including maternal depression and harsh parenting. The nature of youth’s exposure to these stressors (for how long, when in history and development) and the presence of protective adaptive factors (e.g., family socialization practices, youth self-regulation) can moderate stressor impacts on internalizing symptoms. This research will leverage advances in Integrated Data Analysis (IDA) to pool data from five longitudinal Latino/a cohort studies to obtain a single, aggregated data set with 2,515 Latina mother-youth dyads following youth from age 2 to 22 (2010-26). IDA increases statistical power, sample heterogeneity and generalizability, and measurement breadth and depth in ways not possible with a single data set. The application will support 1) collecting cross-sectional data for 500 Latino/a individuals to establish standard measurement scaling across the five studies; 2) integrating data across all five studies; and 3) extracting data from Twitter and the US Census to assess economic stress and neighborhood factors, respectively. Analyses will utilize a general latent variable modeling framework that includes multilevel modeling, structural equation modeling, item response modeling, and finite mixture modeling. We hypothesize a cascade of effects from distal stressors to increased internalizing symptoms through greater proximal stressors and increased family stress processes. We expect that pathways linking societal stressors to youth’s internalizing symptoms will vary depending upon the presence of adaptive factors, the developmental timing and cumulative effects of youth experiences, and sociodemographic characteristics (e.g., youth biological sex). This study offers an unparalleled opportunity to understand Latino/a youth mental health in relationship to multi-level stressors, adaptive factors, and sensitive periods of development. As Latino/a youth comprise more than one-in-four US youth, findings from this research will help identify solutions and guide new preventive interventions and refine existing ones for a large and growing segment of the US population.

Public health relevance
PROJECT NARRATIVE This research will explain how contextual stressors experienced from early childhood into young adulthood affect Latino/a youth’s mental health. Using an integrated data analysis approach, investigators will pool data from five longitudinal cohort studies spanning 2010-2026 to follow 2,515 Latino/a youth and mothers from youth’s age 2 to 22. Knowledge about Latino/a youth’s mental health trajectories within a context of distal stressors and modifiable family stress processes and adaptive factors will inform effective mental health interventions.